Structure/Function of Mn and Fe Superoxide Dismutases

DESCRIPTION (provided by applicant): Superoxide dismutases (SODs) are metalloenzymes containing Mn, Fe, Cu/Zn, or Ni active sites that defend biological systems against oxidative damage mediated by the superoxide radical anion (O2), a product of aerobic metabolism. SODs have also been shown to protect against inflammation and are involved in a range of anti-cancer and anti-aging mechanisms. This proposal focuses on the structurally similar Mn- and Fe-dependent SODs, which accomplish their function through disproportionation of O2 to 02 and H202.The long-term objectives of the research outlined in this proposal are- to identify key geometric and electronic structure contributions to the reactivities of Mn- and Fe-dependent SODs and- to obtain molecular-level insight into the reaction mechanisms of these enzymes.With these goals in mind, the following specific aims have been formulated:- Generate electronic structure descriptions of the oxidized and reduced Mn- and Fe-SOD active sites.- Explore the factors responsible for SOD metal specificity.- Assess the role of second-sphere amino acids in tuning active site properties.- Define the nature of the substrate-metal interaction for Mn- and Fe-SODs and evaluate key steps in the corresponding catalytic cycles on experimental and theoretical levels.Our approach involves using a combination of spectroscopic tools (absorption, CD, MCD, EPR, and rR) and computational methods (DFT and NBO) to study the native Mn- and Fe-SOD proteins, the catalytically inactive metal-substituted Mn- and Fe-SOD species, and several mutant proteins. These studies will systematically explore geometric and electronic factors contributing to SOD activity.As SOD enzymes demonstrate therapeutic efficacy in animal models of disease states involving superoxide, low molecular weight SOD enzyme mimics (synzymes) have been proposed for the treatment of a variety of diseases. Synzymes could have distinct advantages over natural SOD enzymes as pharmaceutical agents, such as cellular permeability, lack of immunogenicity, longer lifetimes, potential for oral delivery, and lower production costs. Thus, understanding the principles by which the Mn- and Fe-SOD enzymes achieve their remarkably high catalytic rates, in particular the influence of second coordination shell amino acids on active site electronics, could aid significantly in the rational design of SOD mimics for pharmaceutical applications.